Project 3 - Characterizing the Amplification Factories of Epstein-Barr Virus and Kaposi's Sarcoma-associated Herpesvirus

PROJECT 3 − SUMMARY/ABSTRACT
Epstein-Barr Virus (EBV) and Kaposi's Sarcoma Herpesvirus (KSHV) cause lymphomas, carcinomas, and
sarcomas in people across the world. No specific anti-viral therapies or vaccines are available now to treat
these tumors or to prevent infections with EBV or KSHV. During the current funding period, we have
developed new technologies and used them to uncover exciting discoveries about entry into and progression
through the productive or lytic phase of the life-cycle of EBV. We have developed live-cell imaging of intact,
infectious genomes of EBV and KSHV and found that during its lytic cycle EBV amplifies its DNA in discrete
sites or factories, mediates a dramatic concentration of cellular chromatin at the nuclear periphery, and inhibits
synthesis of histone chaperones. We have also found that this amplified viral DNA lacks histones and is the
template for viral late gene transcription. We shall examine at the single cell level the formation of both EBV's
and KSHV's amplification factories, their consolidation of cellular chromatin, and their mechanisms of
transcription of viral late genes in these factories. These detailed studies will identify virus-specific processes
that can be targeted to block virus spread.

Public health relevance
PROJECT 3 − PROJECT NARRATIVE Epstein-Barr Virus and Kaposi's Sarcoma Herpesvirus are human tumor viruses that cause many, varied cancers. We shall apply our new technologies and new findings to elucidate at single cell levels how these viruses amplify and transcribe their DNAs during their lytic cycles and thereby learn to limit virus spread.